The Development of Selective Inhibitors to Oncogenic Rac1 Variants

PROJECT SUMMARY
Rac1, a member of the Rho GTPase subfamily, regulates essential cellular functions including
cytoskeletal arrangement, cell motility, cell cycle progression, and proliferation. Dysregulation of Rac1, such as
through the oncogenic P29S mutation or the expression of the alternative splice variant Rac1b, is common in
cancer and contributes to tumor progression, metastasis, and drug resistance. While Rac1 gain-of-function
mutations, amplification, or increased activity of activating proteins are necessary for driving tumorigenesis, the
Rac1b variant alone has also been shown to promote oncogenicity. While Rac1 and Rac1b differ by only a 19-
amino acid insertion after Rac1b's Switch II pocket, this alteration changes the Switch I and II dynamics of
Rac1b, resulting in changes in cellular activity and promotion of tumorigenesis. Furthermore, distinguishing the
roles of these variants in cellular signaling and disease is challenging due to their sequence and structural
similarity, coupled with the scarcity of selective chemical tools for effectively targeting these proteins in cellular
systems. Current inhibitors of Rac1 reversibly target the conserved GEF binding pockets or compete with
GDP/GTP for the conserved Switch I/II region, resulting in compounds with low potency and lack of specificity
to Rac1. Given the differences in the dynamics of the Switch I and II pockets among Rac1 variants, I
hypothesize that targeting these regions will lead to the development of Rac1 variant selective inhibitors. My
preliminary data demonstrates that Switch II pocket inhibitors can exhibit selectivity for Rac1 isoforms, aiding in
understanding their distinct roles in cancer progression. For Aim 1, I will utilize structure-based design to
optimizing selective and cellular active Switch II pocket inhibitors towards Rac1/Rac1b G12C. To assess the
potency and selectivity of these compounds in a cellular system, I will introduce the Rac1/Rac1b G12C
mutation in immortalized cancer cell lines via CRISPR Prime editing. To create therapeutics towards oncogenic
Rac1 variants, Aim 2 of this proposal focuses on developing covalent inhibitors targeting the conserved
cysteine in the Switch I pocket of Rac1 GTPases. This strategy will exploit Rac1 P29S and Rac1b fast-cycling
phenotype and low affinity for GTP to create inhibitors that outcompete GTP for binding the Switch I pocket. In
conjunction with the Arkin lab, I have identified fragments from a disulfide tethering screen with affinity for the
Switch I pocket, which will be optimized for binding Rac1 P29S and Rac1b. Since Rac1 P29S and Rac1b have
different Switch I conformations and lower affinity for GTP than Rac1 WT, I hypothesize that these identified
covalent Switch I pocket binders will preferentially inhibit GTP binding of these oncogenic variants over Rac1
WT. This project aims to create selective chemical tools to elucidate Rac1 isoforms’ role in oncogenesis and
provide therapeutic inhibitors for selectively targeting oncogenic Rac1 variants in cancers. By continuing my
training in integrating chemical genetics and cell biological techniques and leveraging the expertise and
collaborative environment provided in the Shokat lab, I have the tools to successfully complete this project.

Public health relevance
PROJECT NARRATIVE Rac1, a key Rho GTPase involved in cytoskeletal organization, cell motility, and cell cycle progression, is often dysregulated in cancer, leading to progression, metastasis, and drug resistance. Oncogenic variants of Rac1, such as the alternative splice variant Rac1b and the fast-cycling mutation Rac1 P29S, are associated with poor cancer prognosis. This proposal aims to develop chemical tools to distinguish the roles of these oncogenic Rac1 variants in cancer progression and to identify targeted therapeutic strategies for their selective inhibition.